Regulation of Myonuclear Turnover Dynamics in Multinucleated Muscle Cells

Project Summary
Skeletal muscle is comprised of post-mitotic, multinucleated cells that are long-lived and must be maintained
for the duration of an organism’s lifespan. Effective tissue maintenance requires the turnover of damaged
proteins and organelles, including the nucleus. Recent findings clearly demonstrate that muscle stem cells
continue to fuse into muscle fibers throughout adulthood, yet the number of myonuclei remains constant across
the lifespan, suggesting that there must be an opposing mechanism to degrade myonuclei. However, no
mechanism to selectively target and degrade a myonucleus has yet been identified, leading to the longstanding
debate over whether entire myonuclei can be degraded and turned over. The project's overarching goal is to
define the rate of myonuclear turnover in adult skeletal muscles, identify the mechanisms by which myonuclei
are degraded, and unravel the targeting complexes and cellular pathways involved in this process. The central
hypothesis is that accumulation of unrepairable nuclear damage leads to myonuclei undergoing turnover in
adult muscle fibers through ‘nucleophagy’. This hypothesis stems from our preliminary data using a unique
mouse model that exhibits significant myonuclear and DNA damage due to a loss-of-function in lamin A and C
proteins. Using this model, our preliminary data demonstrates that nuclear damage results in enhanced
myonuclear turnover, with damaged myonuclei being enriched in autophagic markers, but not apoptotic
markers. The project comprises three specific aims: firstly, determining the rate of myonuclear turnover across
different muscles and whether this rate changes with physical activity and aging; secondly, exploring whether
myonuclear damage triggers turnover, utilizing transgenic mouse models to induce myonuclear-specific
damage; and finally, investigating the mechanism behind myonuclear degradation, with a focus on
nucleophagy. Findings from this project could fundamentally change how we think about myonuclear and
genomic maintenance during skeletal muscle aging, with additional relevance for the long-term effectiveness of
gene therapy treatments for muscular diseases.

Public health relevance
Narrative Maintaining healthy skeletal muscles is crucial for health and longevity. This project aims to address a critical gap in our understanding of skeletal muscle biology by determining the extent, and underlying mechanism, of myonuclear turnover under resting conditions, with age or in response to exercise. This project has important implications for the maintenance of muscle quality during the aging process, and furthermore, for the potential long-term efficacy of gene therapy strategies for treating muscle diseases.